PCT-KUH: Pittsburgh center for training in kidney, urology and hematology

The Pittsburgh Center for Training in Kidney, Urology and Hematology (PCT-KUH) is designed to prepare
predoctoral students, MDs and PhDs for biomedical research careers by providing a concentrated, in-depth
research experience. This program is designed to foster a rigorous approach to scientific inquiry in basic,
translational or clinical investigation. Our seventy-four training program faculty are members of the University
of Pittsburgh and Carnegie Mellon University. Together they form a well-integrated and collaborative entity
dedicated to research training and investigation in nephrology, benign urology and benign hematology.
Trainees are recruited from divisions and departments at the University of Pittsburgh, Carnegie Mellon
University and the Allegheny Health System. They will develop research projects under the supervision of
faculty trainers and will be closely monitored and evaluated by an advisory committee, career advisors and by
our research training executive committee. Didactic lectures, research seminars, journal clubs, formal course
work, attendance at scientific meetings, professional development programs and networking opportunities
supplement an intensively structured research experience. Predoctoral graduates of this comprehensive
training experience will be equipped to compete for individual training support. Postdoctoral graduates of this
program will be prepared to compete for independent funding and entry-level faculty positions in academic
medicine or industry.

Public health relevance
No PHR